Data Management and Analysis Core

DATA MANAGEMENT AND ANALYSIS CORE: PROJECT SUMMARY
The goal of the proposed program is to obtain in-depth profiles of how human innate and adaptive immune
cells function in response to viral pathogens in tissues and to understand how the circulating responses relate
to those in tissues. Using CMV as a model of infection, we aim to identify signatures for tissue-specific control
of human immune responses for promoting in situ protective immunity in vaccines and immunotherapies.
These efforts will generate thousands of data files representing the results of a diverse collection of assays.
The Data Management and Analysis Core (DMAC) will be responsible for aggregating, annotating, organizing,
analyzing, and disseminating this data. In that role the Core will serve as a centralized resource to support the
shared data management and analysis needs of the Center, offering access to expertise and IT infrastructure
that would be impractical to replicate in the context of individual projects. Specifically, the DMAC will: 1.
Coordinate data curation, storage, and sharing: Data files will have to be accompanied by appropriate clinical
and experimental annotations to support both the program’s own analysis needs as well as requirements for
submission to public NIH repositories. The DMAC will coordinate this information in collaboration with the
relevant projects and cores and will provide access to authenticated, network accessible storage infrastructure
for securely storing and sharing files among investigators. 2. Provide data analysis expertise: The DMAC will
provide projects with analytical expertise to guide the execution of computational investigations. Analyses will
be standardized by leveraging (and adapting, as needed) validated computational pipelines developed to
support the operation of well-established shared resources at the Columbia University Medical Center. The
Core will further utilize and enhance novel methodologies for the analysis of single-cell data and for the
systems-level delineation of the regulatory programs that preside over cell-state transitions in T cells, dendritic
cells, and macrophages.3. Facilitate access to high performance computing infrastructure: The DMAC will
provide investigators access to sophisticated IT infrastructure designed specifically to support the needs of
biomedical research at the CUMC, including fast, network-accessible disk storage and a powerful
computational cluster that is among the most advanced in the nation dedicated to biomedical research.
4. Coordinate data dissemination: A key goal of the HIPC program is timely dissemination of the data
generated by all awardees to the public repositories. The process requires the compilation of comprehensive
documentation to ensure that the data released are interpretable. The DMAC will be responsible for preparing
all necessary data submissions, interfacing with repository personnel and ensuring that submission packages
are fully annotated, per repository requirements.